Specificity of ABCA7-mediated lipid efflux and its effects on intracellular lipid metabolism in neural cells

Project Summary/Abstract
Alzheimer's disease (AD) dementia has emerged as a major burden on the healthcare system and a major
barrier to human longevity, especially productive human longevity. Genetics of familial early-onset AD,
pathological changes in the brain of sporadic late-onset AD patients and pathological changes in the brain of
individuals with Down syndrome, who frequently have increased expression of amyloid precursor protein (APP)
owing to partial trisomy of chromosome 21, all point to APP and its cleavage product amyloid β (Aβ) peptide as
major causative factors in AD pathogenesis. However, other factors may also play a role. The genome-wide
association studies (GWAS) of the architecture of common genetic predisposition to AD, genetic investigations
of rare loss-function mutations and studies in mouse models of AD have implicated ATP-binding cassette
transport subfamily A member 7 (ABCA7) in AD pathogenesis. A closely related protein, ATP-binding cassette
transport subfamily A member 1 (ABCA1) has been implicated in AD in the GWAS and animal studies. In our
preliminary data, we show that individuals with low ABCA7 protein levels have a greater risk for developing AD
pathology. Both ABCA1 and ABCA7 mediate formation of high-density lipoprotein (HDL) particles from cell
lipids. In preliminary data, we show that ABCA7- and ABCA1-HDL significantly differ in the lipid composition.
Recently, we published the altered lipidostasis hypothesis that draws on the paradigms provided by ABCA1
and another ABC A transporter, ABCA4, and poses the existence of a neurodegenerative lipid that
continuously arises during normal physiology and promotes AD pathogenesis when it is not eliminated from
neural cells by ABCA7. ABCA1 and ABCA4 eliminate from specific cells deleterious lipids that these cells
accumulate during normal function. The purpose of the present exploratory project is to conduct comparative
ABCA7 vs ABCA1 studies in specificity of lipid efflux in neural cells and to test the prediction of the lipidostasis
hypothesis of AD that in the neural tissue ABCA7 mediates efflux of a specific lipid species (i.e., the
neurodegenerative lipid) that is not effluxed significantly by ABCA1. To test this prediction, we will use
metabolic radioactive labeling of lipids/high performance thin layer chromatography (HPTLC) and
multidimensional electrospray
ionization
`shotgun' mass spectrometry lipidomics to compare ABCA7- and
ABCA1-mediated lipid efflux/HDL and the effects that this efflux/HDL formation has on the lipid composition of
the plasma membrane and whole cell in microglia C20, astrocyte glioblastoma A172 and neuroblastoma SK-N-
SH cells inducibly expressing ABCA7 or ABCA1.

Public health relevance
Project Narrative Genetic studies in human populations have found that the gene known as ABCA7 may bear on whether individuals develop Alzheimer’s disease (AD) or not. The purpose of this project is to determine biochemical functions of this gene. Longer term, the investigators would like to use the knowledge gained about how ABCA7 affects AD to develop a therapy against the disease.